Clinical Practice Network

PROJECT SUMMARY/ABSTRACT
The purpose of the Clinical Practice Network (CPN) of the MATCHES Telehealth Research Center is to provide the environment for conducting and evaluating the Center’s investigations of telehealth-supported cancer care. MSK’s New York City locations and six regional care sites will constitute the CPN. MSK is a high volume cancer center with a robust infrastructure for delivering telehealth via both synchronous and asynchronous technologies. As such, the CPN also will serve as the Center’s practice innovation and digital innovation hub for implementing and evaluating telehealth, as well as nimbly translating the generated evidence back into clinical practice. The CPN will convene patients, clinicians, staff, and scientists to test and refine telehealth solutions, and novel computational and hybrid practice models, all based on principles of user-centered design. The CPN’s specific aims are 1) to develop and deploy enhanced telehealth tools, 2) to develop and deploy MSK@Home telehealth-supported services in the context of the Center’s Pragmatic Trial, 3) to identify and implement efficient methods of patient and clinician engagement to refine telehealth-enabled interventions, and 4) to test and refine novel computational, operational, and staffing models for the delivery of telehealth-supported cancer care at home.

Led by Peter D. Stetson, MD, MA, with Gilad J. Kuperman, MD, PhD, and support from a multidisciplinary leadership team from across MSK, the CPN will act as the effector arm and feedback sensor for implementing the MSK@Home intervention to be evaluated via our Pragmatic Trial and will perform similar functions across the planned pilot studies. It will orchestrate the deployment of telehealth solutions across the study sites, as well as coordinate data collection and management for the study interventions. The CPN team will establish and monitor the experience of patients, clinicians, and front-line staff through regular review of key success metrics with the Administrative Core’s Patient Engagement Unit and Clinician & Staff Engagement Unit. The CPN team will develop and deploy a novel, standardized common data model for telehealth and patient-generated health data. They will extract, aggregate, and deliver multimodal data insights from the telehealth platform and additional key systems for operational leadership in the CPN to adjust to conditions on the ground, as well as for the data scientists in the Research & Methods Core to develop new digital biomarkers and computational models. The CPN team will manage the process to adjust implementation of the study interventions as a result of change in regulatory and financial requirements and as cancer centers evolve best evidence in the use of telehealth.